Investigating the role of ELAVL1 as a post-transcriptional regulator of cranial neural crest development

PROJECT SUMMARY/ABSTRACT
The neural crest (NC) is a multipotent stem cell population that is critical for normal craniofacial
morphogenesis in vertebrates. During NC development, NC cells delaminate from the neural tube and migrate
throughout the developing embryo. The cranial NC ultimately differentiates into various structures of the head
and face, including the craniofacial skeleton and cranial sensory ganglia. For cranial NC cells to properly
contribute to these structures, they must undergo an epithelial-to-mesenchymal transition (EMT), which allows
these cells to migrate to their correct destinations. Perturbing one or more events of NC development results in
structural craniofacial defects (e.g. cleft lip/palate) and abnormal trigeminal sensory innervation. Thus, a
thorough understanding of cranial NC development is essential for identifying the etiology of craniofacial
abnormalities. Recently, ELAVL1, a ubiquitous RNA-binding protein, was discovered to have critical regulatory
roles in premigratory cranial NC to correctly time the onset of EMT. My preliminary findings suggest that
ELAVL1 continues regulate cranial NC development following EMT, during cranial NC migration and
subsequent cranial gangliogenesis. The goal of this Proposal is to characterize the role of ELAVL1 during
cranial NC development and trigeminal gangliogenesis in the chick embryo. The findings of this study will
advance our current understanding of the etiology of craniofacial anomalies, and more specifically, contribute
basic scientific knowledge essential to understanding neurocristopathies, particularly those affecting
somatosensory perception in the head and face.

Public health relevance
PROJECT NARRATIVE Dysregulated cranial neural crest (NC) development leads to structural craniofacial defects (e.g. cleft lip/palate) and abnormal trigeminal sensory innervation. This project will investigate how ubiquitous RNA- binding protein, ELAVL1 regulates cranial NC migration and subsequent cranial gangliogenesis. The findings of this study will advance our current understanding of the etiology of craniofacial anomalies, and more specifically, contribute basic scientific knowledge essential to understanding neurocristopathies, particularly those affecting somatosensory perception in the head and face.